Physical laws to control and regulate composition of multi-component biomolecular condensates

Abstract
Biomolecular phase separation is a fundamental process in biology which facilitates many biological functions.
Through the process of phase separation, cells can compartmentalize certain molecules into a highly-
concentrated condensed phase – commonly termed a condensate, or membraneless organelle (MLO) – that is
distinct from the surrounding environment. These MLOs are important to biology because they are functionally
distinct from their membrane-bound counterparts, and can be regulated by external stimuli, sometimes forming
or dissociating spontaneously upon a change in conditions in the surroundings. Usually, MLOs are stabilized by
a small subset of molecules, such as multivalent proteins containing intrinsically disordered regions, but contain
dozens to hundreds of other proteins, nucleic acids, and other molecules. It is important to understand the
physics and molecular interactions that determine the relative composition, and how this relates to the function
and efficiency of an MLO. This is especially important for development of novel drugs that target proteins and
nucleic acids within disease-causing condensates in biology. I plan to develop my research program to tackle
important problems in this field by developing theoretical models to describe interactions and phase separation
of multi-component mixtures of proteins and other biomolecules. Successful completion of this work will enable
researchers to make predictions of how biomolecules contribute to phase separation in a multi-component
system. We will also work to understand how MLOs are regulated by cellular conditions such as temperature,
pH, or concentration of salt and other small molecules. We particularly wish to focus on the question of how
phase separation is controlled by the presence of small molecules, such as metabolites, or pharmaceutical
drugs. By working with theoretical and computational methods, we can consistently model the interactions of
small molecules with MLO constituents, and how they partition inside a condensate. Successful completion of
this work will contribute greatly to the community's understanding of how condensates are regulated and provide
important design principles for small molecule, and biologic drugs developed specifically to target MLOs.

Public health relevance
Project Narrative Membraneless organelles are an essential component of life, and are composed of many types of proteins and nucleic acids. Their function is related to the total and relative concentrations of each component, and regulated by external factors. Using computational molecular physics, we will study how interactions between molecules are predictive of compositions of membraneless organelles, and how external stimuli regulate these interactions.